Dissecting the role of the bed nucleus of the stria terminalis in avoidant behavior

PROJECT SUMMARY/ABSTRACT
Avoidance is a hallmark symptom contributing to the deleterious impact of many anxiety disorders.
Despite this, there are major gaps in our understanding of the neural circuits underlying avoidant behavior. A
mechanistic account of this key symptom would advance progress toward brain-based innovations for the
treatment of pathological anxiety.
Signaled active avoidance (SAA) is a behavioral procedure for rats in which a highly persistent avoidance
response is triggered by a conditioned stimulus (CS) associated with an aversive unconditioned stimulus (US).
Because the avoidance response prevents US delivery, acquisition of SAA causes the US to transition from an
imminent threat early in training to a remote threat later in training, once the response has become more frequent.
Ethologically inspired models for aversive emotion suggest that this change in threat imminence is consistent
with a shift from fear to anxiety, indicating that SAA expression is mediated by an anxiety-like state. The
overarching hypothesis of this proposal is that neural circuits of anxiety-like behavior play a central role in SAA.
Previous work implicates the bed nucleus of the stria terminalis (BNST) in anxiety. To generate
preliminary data for the overarching hypothesis of this proposal, an initial experiment was conducted using an
inhibitory DREADD (designer receptor exclusively activated by designer drugs) to inactivate BNST neurons in
rats performing SAA. This manipulation demonstrated that BNST is necessary for the maintenance of the
avoidance response. The proposed studies will build on this result by dissecting the function of a circuit
mechanism for active avoidance, comprised of BNST and key regions that provide it with synaptic input
(prefrontal cortex, basal amygdala).
Given that avoidant coping is a behavioral disturbance common to many anxiety disorders, this work has
clear relevance to public health. Discovery of an avoidance circuitry could provide a novel target for innovative
therapeutic interventions for pathological anxiety. The goal of this work is to generate rigorous preclinical data
that accelerates clinical advancement.

Public health relevance
PROJECT NARRATIVE An avoidant style of coping is a unifying feature of many anxiety disorders that contributes substantially to the debilitating life impact of these conditions. The proposed research will explore the role of circuit centering around the bed nucleus of the stria terminals in avoidant behavior. If successfully fulfilled, our hypotheses could provide novel targets for innovative, brain-based therapeutic approaches to anxiety disorders.